Comparative Biology of Tissue Repair, Regeneration and Aging

Project Summary
The goal of the COBRE-II parent award at MDIBL is to study the intersection of stress, aging, and
regeneration using comparative functional genomic studies of appropriate model organism systems. In the
current proposal, Dr. Murawala (RPL within COBRE II at MDIBL) will team up with Dr. Arturo Hernandez (Faculty
scientist III, MHIR) and Dr. Joel Graber (Director, MDIBL Computational Biology Core) to perform comparative
studies the effect of thyroid hormone-induced metamorphosis in axolotl and mouse using next-generation
methodologies. Dr. Murawala will focus on understanding the thyroid-hormone induced changes in axolotl skin
using multiome and spatial transcriptome technology of 10X Genomics, Dr. Hernandez will perform
complementary experiments in mouse models, and Dr. Graber will refine the axolotl-mouse orthology mapping
and will use this updated information to analyze and compare multiome and spatial data from the Murawala lab
and Hernandez labs.
The work proposed here will allow us to generate valuable comparative datasets that will 1) provide
crucial insights into pathophysiology of skin upon abnormal thyroid hormone signaling and 2) form the basis for
future larger grants aimed at elucidating the role and underlying mechanisms by which thyroid hormones regulate
tissue maturation and regenerative capacity.

Public health relevance
Project Narrative Activation of the thyroid pathway negatively influences wound healing by remodeling skin tissues, but the underlying mechanisms are poorly understood. We will combine expertise of the Murawala lab (axolotl biology), Hernandez lab (thyroid biology in mouse models) and MDIBL Computational Biology Core to perform a comparative study of the effects of thyroid hormone exposure on mouse and axolotl skin. The knowledge gained from this study will pave the way for our future studies aimed at understanding the cellular and molecular mechanisms that regulate fibrosis and wound healing in models of injury across species.